The effect of SPecialty cAre on Recovery from Cardiac arrest (the SPARC trial)

Abstract
Cardiac arrest is common and deadly. Over 150,000 Americans are admitted to the hospital after resuscitation
from cardiac arrest each year. These vulnerable patients require complex and time sensitive care to treat the
causes and consequences of cardiac arrest. Delivery of excellent post-arrest care improves survival and
quality of recovery. Unfortunately, hospital-level variability in case volume, resources, and provision of
recommended treatments results in tens of thousands of avoidable deaths annually. For these reasons, the
American Heart Association and National Academies of Medicine recommend comprehensive systems of post-
arrest care be created, which may include specialized centers. What comprises these systems and specialty
centers remains a key knowledge gap. This randomized controlled trial will test the effect of transfer to an
existing specialty center compared to usual care for patients resuscitated from out-of-hospital cardiac arrest.
Our results will define the value of a specialized system of care and identify the necessary minimum
components needed to confer benefit from specialty care. This single system, regional Phase II trial will allow
future multicenter implementation and testing of specialty care by: 1) estimating the effect of transfer to
specialty care on functional recovery after cardiac arrest in an optimal environment; 2) leveraging variability in
participating usual care centers to elucidate the minimal clinical and operational standards for specialty cardiac
arrest centers; and, 3) rigorously characterizing ancillary costs and benefits of transfer to specialty care. This
trial will inform public policy and the clinical approach to one of the most lethal syndromes in medicine.

Public health relevance
Project narrative Patients resuscitated from out-of-hospital cardiac arrest are critically ill and may benefit from care delivered at specialized cardiac arrest centers. This is the first trial to assess the advantages of interfacility transfer to specialty care compared to usual care for these vulnerable patients. This trial’s outcomes will directly impact clinical practices, public health policies, and research design by determining if transfer to specialty care improves functional recovery after cardiac arrest, by defining operational standards for cardiac arrest centers, and by evaluating thoroughly the intervention’s benefits and costs for patients, caregivers, and society.